Receptor-mediated Control of Pulmonary Ionocytes

PROJECT SUMMARY/ABSTRACT
Maintaining the appropriate volume of airway surface liquid is crucial for respiratory health. Airway epithelia
control airway surface liquid volume by balancing the absorption and secretion of liquid. Recent studies re-
vealed that ionocytes perform most of the salt and liquid absorption, and secretory cells perform most of the
secretion. Both cell types use cystic fibrosis transmembrane conductance regulator (CFTR) channels to control
Cl– movement across the apical membrane. This raises the question—how do airway epithelia balance the
contributions of two neighboring cell types that perform opposing functions through the same apical channel?
The long-term goal is to establish new regulatory nodes between ion transport, its regulation, and physiological
function and then target these mechanisms in pulmonary diseases. The overall objective of this application is
to define the mechanism by which PGE2 balances absorption and secretion to target novel mechanisms that
control airway surface liquid volume. The central hypothesis is that PGE2 production balances ASL absorption
and secretion by regulating ionocytes and secretory cells simultaneously. The central hypothesis will be tested
by pursuing the following specific aims posed as questions: 1) How does PGE2 balance airway epithelial Cl–
absorption and secretion? 2) How does PGE2 modify the ASL? The proposed research is innovative because it
tests the hypothesis that PGE2 turns off CFTR in ionocytes while turning on CFTR in secretory cells. The
mechanism is the first example of how one molecule can control CFTR in two neighboring cells performing op-
posing functions. The proposed research is significant because results identify new targets for therapeutic in-
terventions in pulmonary diseases.

Public health relevance
PROJECT NARRATIVE The proposed research is important for public health as it focuses on a new way by which the prostaglandin PGE2 maintains the volume of airway surface liquid which is often disrupted in airway diseases. By testing the signaling mechanisms in this pathway, this research will provide the fundamental knowledge required to use the various prostaglandin-based pharmaceuticals available to restore airway surface liquid volume. Therefore, this research is highly relevant to NIH's mission to seek fundamental knowledge about the nature and behavior of living systems and the application of that knowledge to enhance health, lengthen life, and reduce the burdens of illness and disability.